UTMB Health Services Research Training Program

PROJECT ABSTRACT/SUMMARY
This new T32 program for Heath Service Research at the University of Texas Medical Branch (UTMB) seeks
funds for 5 years to support 3 predoctoral trainees per year. The program aims to increase and improve the
pool of health service researchers with clinical background to help address complex issues in health care
delivery in the US. Given our strengths in the areas of health service research, we focus on using cutting edge
methodology to study the patterns and trends of health care delivery, to assess the impact of health policy, and
to examine the effectiveness of various care models. The trainees are PhD or MD-PhD students in the
Population Health Science program, Clinical Science program, or Rehabilitation Science program of the
Department of Preventive Medicine and Community Health.
UTMB has an excellent record in conducting health service research. We were funded by an R24 on Health
Service Research in Underserved Population between 2001 and 2006 from the Agency for Healthcare
Research and Quality (AHRQ). Since then, we have continuously developed health service research with two
R01s and an R24 on Patient Centered Outcomes Research in the Elderly, currently funded by AHRQ. Besides
funding from AHRQ and several additional health service research R01s from the NIH, we also have a P2C
grant for the Center for Large Data Research and Data Sharing in Rehabilitation funded by the National
Institute of Child Health & Human Development and another Multi-Investigator Research Award on
Comparative Effectiveness Research on Cancer in Texas funded by the Cancer Prevention & Research
Institute of Texas. The current faculty in the affiliated departments have strengths in biostatistics, epidemiology,
economics, computer science, sociology, medicine, health policy, and rehabilitation. We plan to build on our
strengths and train health care professionals in health service research in different populations. As is the case
in our other programs, special efforts will be made to recruit students from diverse clinical backgrounds, and all
our trainees will focus their health service research in their clinical field. The Graduate School of Biomedical
Sciences and Provost's Office have made significant commitments in the past 5 years to enhance the
excellence of graduate education at UTMB. These commitments include the President's Scholars Program to
recruit outstanding graduate students and the establishment of an Office of Postdoctoral Affairs that includes
organized training and opportunities in career development and mentoring. We have developed a formal
structure and related activities to enhance recruitment and facilitate the placement of our trainees regionally
and nationally. We believe that our health care profession trainees will be competitive for leadership positions
among the next generation of health service researchers in their clinical area.

Public health relevance
PROJECT NARRATIVE The proposed program for health services research aims to increase and improve the pool of health service researchers with clinical background to help address complex issues in health care delivery at US, by training pre-doctoral students. The participating faculty members have extensive experiences using cutting edge methodology to study the patterns and trends of health care delivery, to assess the impact of health policy, and to examine the effectiveness of various care models.